Neural Correlates of Implicit Processes of Attention & Emotion in Alcoholism

DESCRIPTION (provided by applicant): Deficits in impaired inhibitory control functions and in sustained goal-directed behavior have long been identified as key features of alcoholism. Alcohol-use disorders (AUD) are also associated with abnormalities in emotional processing, with a number of studies reporting that selective brain systems that engage the amygdala play a crucial role in a tendency to experience negative emotion and in promoting alcohol intake. Delineation of the interplay between voluntary cognitive control (conceived as an explicit or "top-down" process that require allocation of attentional resources) and emotional responsiveness (conceived as an implicit or "bottom-up" process) is fundamental for understanding behavioral regulation and emotionally motivated actions towards alcohol misuse. The extent to which excessive alcohol use contributes to deficits in cognitive control or to enhanced automatic responsiveness is unknown but can be interrogated experimentally by presentation of affectively laden stimuli. Our recent behavioral studies indicate both disturbed bottom-up processing of redundant sensory information and impaired top-down control of conflict resolution in chronic alcoholics, and lay the foundation for the proposed studies. The primary goal of this project is to identify the neural correlates of implicit bottom-up influences and top-down regulation of emotion and cognition in alcoholism through the use of functional magnetic resonance imaging (fMRI), conventional MRI, and diffusion tensor imaging (DTI), noninvasive, in vivo methods for studying the functional, macrostructural, and microstructural architecture of the brain. The specific aims of this proposal are to (1) determine how chronic alcoholics differ from controls in component processes of attention-emotion regulation, (2) identify the neural correlates of attention-emotion systems in alcoholism with fMRI, and (3) determine the effects of alcoholism on relationships among regional microstructural brain status (DTI), functional brain networks (fMRI), gray matter foci (MRI), and performance measures. We propose a series of behavioral, structural, and functional MRI studies of attention-emotion processing to examine the extent to which alcoholics have selectively disrupted or preserved automatic bottom-up and attentional top-down control processing of emotional stimuli. The identification of sources of disruption of neural systems of attention and emotion should lead to an understanding of the impact of implicit and explicit control of behavior and has implications for developing interventions for improving cognitive behavioral therapies in individuals with AUD. PUBLIC HEALTH RELEVANCE: Alcoholics, even when abstinent, often have to exert voluntary control to suppress the urge to drink. The purpose of this proposal is to use brain imaging to understand the neural basis of the drive to alcoholic drinking and its control, which in turn may lead to treatments for maintaining sobriety and preventing relapse.

Public health relevance
Project narrative Alcoholics, even when abstinent, often have to exert voluntary control to suppress the urge to drink. The purpose of this proposal is to use brain imaging to understand the neural basis of the drive to alcoholic drinking and its control, which in turn may lead to treatments for maintaining sobriety and preventing relapse.